Oxalobacter formigenes-derived Factors Impact Hyperoxalemia, Hyperoxaluria, and Related Kidney Stones

Project Summary/Abstract:
Kidney stones (KS) affect ~1 in 5 men and ~1 in 11 women, are very painful & costly (>$10B annually), and are
associated with CKD and ESRD. High recurrence rates (50% in 5 years) indicate that current interventions are
inadequate and alternative therapies are needed. Most KS are composed of calcium oxalate, and small
increases in urine oxalate enhance the risk for stone formation. Lower urinary calcium oxalate supersaturation
definitively reduces KS formation, but unfortunately there are no drugs that reduce urinary oxalate excretion. The
gut bacterium Oxalobacter formigenes (Of) induces colonic oxalate secretion and reduces urinary oxalate
excretion via an unknown secretagogue. Given the difficulties with recolonization, Of alone is not therapeutically
feasible and underscores the need to identify the secretagogue. We identified Of-derived factors secreted in its
culture conditioned medium (CM) that stimulate (>2.8-fold) oxalate transport by human intestinal Caco2-BBE
(C2) cells through PKA activation and stimulation of the oxalate transporters SLC26A6 (A6) and SLC26A2 (A2).
In vivo, rectal administration of CM reduced urinary oxalate excretion >32.5% and stimulated colonic oxalate
secretion >42% in hyperoxaluric mice, reflecting the therapeutic potential of these factors. We have identified
Sel1 proteins as the major Of-derived factors and they similarly stimulate (1.4-2.4-fold) oxalate transport by C2
cells via PKA and the A2/A6 transporters. We also identified small peptides (P8+9) within a Sel1 protein that
stimulate (>2.4-fold) oxalate transport by C2 cells. P8+9 also stimulated oxalate transport by human sigmoid
colon (1.8-fold), distal colon (1.7-fold), and ileum (2-fold) organoids (ex vivo intestinal epithelia models fully
mimicking the in vivo responses), confirming that P8+9 work in human tissues and that they will likely stimulate
oxalate secretion in human colonic and ileal epithelia in vivo.
Based on these findings I will test the hypotheses that specific P8 and P9 subdomains mediate colonic oxalate
secretion and potential therapeutic motifs can be identified, and that P8+9 act via cell surface receptors and
specific signaling pathways to activate the involved oxalate transporters (including A2, A6, and perhaps others).
The following specific aims will be pursued: 1. Identify the P8 and P9 peptide subdomains that stimulate oxalate
transport in C2 cells and human organoids: 1a Identify the shortest functional P8 and P9 peptides subdomains
by deleting specific amino acid residues. 1b. Identify the critical amino acid residues in P8 and P9 peptides using
a substitution approach. 2a. Identify the involved cell surface receptor(s) in C2 cells. 2b. Define the signaling
pathways mediating stimulation of oxalate transport in C2 cells. 2c. Identify the oxalate transporters and the
mechanisms by which P8+9 activate them in C2 cells and use A6 null mice to confirm the in vivo role of A6.
Achieving the project’s objectives will have therapeutic implications for the prevention and/or treatment of
hyperoxalemia and hyperoxaluria, impacting the outcomes of patients suffering from CaOx KS, enteric
hyperoxaluria, primary hyperoxaluria, and possibly CKD and ESRD.

Public health relevance
Project Narrative: Hyperoxaluria is a major risk factor for kidney stones (KS) and has no therapy. Defining the mechanisms by which Oxalobacter-derived peptides stimulate intestinal oxalate secretion, including characterization of the active peptide motifs and downstream signaling events, can lead to a novel drug for hyperoxaluria and related KS.